ELUCIDATING MECHANISMS OF CELL COMPETITION DURING DEVELOPMENT -Diversity supplement

Project Abstract
No changes from the parent grant.

Public health relevance
Project Narrative No changes from the parent grant.